Substance Use and Treatment Among American Indian/Alaska Native Veterans: Foundation Building for a Comprehensive Community-Partnered Type I Hybrid Intervention Study

ABSTRACT
Substance use disorders (SUD) are common, chronic, and associated with substantial death and despair but
can be treated. American Indian/Alaska Native (AI/AN) populations are vulnerable to health and healthcare
disparities and increased likelihood of SUD due to colonialism, historical trauma, and structural racism.
Understanding substance use and its treatment among AI/AN Veterans would fill a major knowledge
gap and provide needed foundation for development and testing of a culturally appropriate SUD
intervention that can be built on strength and resilient factors among AI/AN Veterans and delivered in
clinical settings. Guided by Public Health Critical Race (PHCR) praxis, the mixed-methods parent R01
provides a unique and synergistic opportunity to conduct needed foundational clinical epidemiology and in-
depth qualitative work to inform development of an intervention that can be tested in a Type I Hybrid design.
The proposed supplement capitalizes on this rich foundation and substantial upfront investment from NIDA to
add an unprecedented and community-engaged line of inquiry into substance use and its treatment among
AI/AN Veterans and support culturally appropriate intervention development. The overall goal of the proposed
supplement is to build on the resources developed through the parent study to conduct research in partnership
with AI/AN community members and guided by PHCR to provide the foundation for developing a Hybrid Type I
study of a culturally appropriate, strengths-based intervention. The specific aims, all of which will be guided by
community partners, include: Aim 1) Describe the prevalence of unique substance use disorders among AI/AN
Veterans, overall and relative to White Veterans, and identify multilevel factors associated with SUD among
AI/AN Veterans; Aim 2) Describe receipt of and multilevel factors influencing evidence-based treatment (e.g.,
specialty addictions treatment and/or receipt of effective pharmacotherapies) among AI/AN Veterans with
SUD, and compare likelihood of receipt to those of White Veterans with SUD; Aim 3) Understand experiences
of SUD, their treatment, and multi-level lived experiences that influence these among AI/AN Veterans through
in-depth qualitative interviews with ~40 AI/AN Veterans. The proposed community-partnered innovative
foundational study will be the first to our knowledge to describe the prevalence of SUD and its treatment, as
well as multi-level factors that result from structural racism to influence these experiences, among AI/AN
Veterans. It is also the only study to our knowledge to obtain in-depth qualitative information to understand the
lived experiences of AI/AN Veterans with SUD and how they influence SUD treatment and the multi-level
factors that influence both. Together the planned activities will provide foundational data and community
engagement we need to design a community-engaged, culturally appropriate intervention to decrease SUD
and increase SUD treatment among AI/AN Veterans whose lived experiences are heavily influenced by
uniquely American structural racism.

Public health relevance
Rooted in colonialism, historical trauma, and structural racism, American Indian and Alaska Native (AI/AN) populations experience major disparities in substance use and related adverse outcomes—particularly AI/AN Veterans—but these disparities remain vastly understudied. Our team of Indigenous and non-Indigenous researchers and our rich foundation of substantial upfront investment from NIDA via a parent R01 create a unique opportunity to add an unprecedented and community-engaged line of inquiry into substance use and its treatment among AI/AN Veterans to support culturally-appropriate intervention development. We will conduct community-partnered clinical epidemiologic and qualitative research to inform development of a culturally appropriate and strengths-based intervention that addresses substance use among AI/AN Veterans in clinical settings and can be tested using a Hybrid Type I design to inform effectiveness and implementation.